New tools to translate time across the lifespan in humans and model organisms

Project Summary/Abstract
The goal of this project is to identify corresponding ages across postnatal ages in humans and model organisms.
This work is needed because scientists often use model organisms such as mice to understand basic biological
processes and disorders in humans, but there is currently no resource that enables researchers to find
corresponding ages across the lifespan of model organisms and humans. We and others have implemented an
easily accessible website to find equivalent developmental ages across 18 mammalian species
(http://www.translatingtime.net). This resource is used by a number of researchers who study model organisms
(e.g., mice) to translate their findings to humans, but it only finds corresponding ages up to 2 year after birth in
humans and its equivalent in model organisms. This is because we focused on sharp changes that occur during
neurogenesis (i.e., the production of neurons) as a basis with which to find corresponding ages across species.
Neurogenesis occurs largely during fetal development. As a result, we have only identified corresponding ages
during fetal and early postnatal development in humans and and model organisms. Yet, many researchers use
model organisms to understand human childhood, adolescence, and aging, and there is no resource that
enables scientists to find corresponding ages between humans and other species across the lifespan. We will
compare the timing of tract (i.e., pathway) maturation and temporal changes in gene expression across species
in order to identify corresponding transformations during postnatal and adult ages in humans and their
equivalent in model organisms. We will use diffusion MR tractography, which identifies tracts across the brain, to
compare the timing of tract maturation across postnatal development in humans, non-human primates, and
mice. We will use RNA sequencing to track temporal changes in gene expression across postnatal ages in
humans, non-human primates, and mice. Integrating diffusion MR tractography with gene expression is an
innovative approach with which to find corresponding ages across the lifespan of humans and model organisms.
This project will implement new tools with which to find corresponding ages from model organisms to humans.

Public health relevance
Project Narrative The proposal will identify equivalent ages across postnatal ages in humans and model organisms. This work is important because researchers often use model organisms to understand biological processes and dysfunctions in humans, and this work will enhance translating findings from model organisms to humans.